Addressing Disparities in Outcomes of Screening for Colorectal Cancer in Community-Based Settings

PROJECT SUMMARY/ABSTRACT: Colorectal cancer (CRC) is the second leading cause of cancer deaths in
the United States and although the overall CRC mortality rate has been decreasing, disparities have persisted,
particularly for Black and Native American people. CRC screening is highly effective and there is a welcome
national attention on improving access to screening for groups that are socially disadvantaged. However, the
benefits of screening depend on receiving both high-quality testing and timely follow-up care when abnormal.
Thus, disparities may persist even when rates of participation in screening are similar across populations.
Recently, the US Preventive Services Task Force highlighted a gap in the understanding of CRC disparities and
the relative lack of interventions that have been shown to eliminate disparities by race and ethnicity. The goal
of this application is to inform feasible and effective strategies for advancing health equity by elucidating the
extent to which differences in care along the entire screening process cumulatively contribute to disparities. We
will comprehensively evaluate the entire screening continuum from the tests used and screening quality to
receipt of follow-up care and guideline-concordant treatment in a cohort of about 3.8 million people per year
over a nearly 2-decade period in Kaiser Permanente Northern California (KPNC) and Kaiser Permanente
Southern California (KPSC). We will use a mixed methods approach informed by health equity frameworks to
examine: 1) the receipt and quality of screening for CRC, including follow-up when abnormal; 2) post-screening
treatment and disease outcomes, including interval CRCs, 5-year survival, and age-standardized incidence and
mortality, overall and by location; 3) the reasons for variations in quality and timely follow-up using qualitative
interviews; and 4) the relative contributions of differences along the screening continuum to disparities in
mortality by using microsimulation modeling. We will conduct our studies in a dynamic cohort of 45-85-year-old
men and women in KPNC/KPSC during the 2003-2019 period. The members of KPNC and KPSC mirror the
characteristics, in terms of social factors, of people in the regions served across California. The complete
capture of all screening steps and diverse, well-defined populations enable studies of strategies across the
screening continuum among social groups. Our analyses will compare the racial and ethnic groups and
stratifications by race for each outcome over a nearly 2-decade period. We will interview patient-clinician dyads
to elucidate reasons for variations in quality, follow-up, and outcome. We will also use the MISCAN-Colon
microsimulation model to examine the extent to which disparities in mortality are attributable to differences found
across each step in the screening continuum. The proposed research has a high potential to inform the
prioritization of strategies for advancing health equity across disadvantaged racial and ethnic minority groups
and thus advance a national public health priority. The 1½ decades of high-impact collaboration in our team,
and the setting and rigor of our application support the feasibility and high potential for impact in the field.

Public health relevance
PROJECT NARRATIVE Colorectal cancer is the second leading cause of cancer death in the United States and disparities in mortality by race and ethnicity persist. This application seeks to elucidate why colorectal cancer disparities may persist even when similar rates of screening have been achieved by comprehensively evaluating the entire screening continuum from the tests used and screening quality to follow-up care and guideline-concordant treatment in a dynamic cohort of about 3.8 million people per year over the 2003-2019 17-year period. We will perform mixed- methods studies among people 45-85 years old in Kaiser Permanente in both Northern and Southern California and model the extent to which differences along the screening process cumulatively contribute to disparities.